GOVERNMENT UNIVERSITY INDUSTRY RESEARCH ROUNDTABLE (GUIRR) AND THE FEDERAL DEMONSTRATION PARTNERSHIP (FDP)

The Government-University-Industry Research Roundtable (GUIRR), created in 1984, provides a unique forum for dialogue among top government, university and industry leaders of the national science and technology enterprise. The Roundtable is sponsored by the National Academy of Sciences, the National Academy of Engineering, and the Institute of Medicine. It is guided by a Council that sets the Roundtable agenda, addresses some topics directly, and oversees the plans and activities of Working Groups appointed to examine additional topics in depth.